Molecular Biology and Cytometry Research Shared Resource

MOLECULAR BIOLOGY AND CYTOMETRY RESEARCH SHARED RESOURCE – ABSTRACT
The Molecular Biology and Cytometry Research Shared Resource (MBCR SR) is an institutionally managed
central core facility that assists investigators in all aspects of research, including initial project consultation,
assistance with experimental design, training in protocols and instrumentation usage, sample preparation, data
collection and assistance with analysis and interpretation of results. Under the direction of James Tomasek,
PhD, the OUHSC Vice President for Research, the MBCR SR provides four important Core services to SCC
members and other investigators: 1) the DNA Sequencing and Genomics Core provides investigators with
access to high-fidelity, next-generation nucleic acid sequencing data; 2) the Mass Spectrometry and
Proteomics Core provides proteomics support for biomolecule identification, including complex proteomics
analysis, post-translational modification identification, high-resolution molecular weight determination, large
biomolecular mass measurements, LC-UV-MS analysis (qualitative or quantitative), protein identification by
proteolytic digest (in-gel or in solution), nano LC/MS/MS and database search, and peptide sequencing; 3) the
Flow Cytometry and Imaging Core provides flow cytometry and microscopy support for subcellular studies on
protein expression, cell cycle and cell signaling; and 4) the Cancer Functional Genomics Core provides cutting-
edge technology and services for high-throughput live cell functional characterization of cancer cells, including
reverse proteomics array establishment, absolute gene quantification and copy number determination, nucleic
acid and protein electrophoresis and imaging, multimodal screening for high-throughput assay on plates, high-
throughput, high-content screening of subcellular localized proteins in cells, metabolic analysis of live cells and
quantification of clonogenic assay colonies of cancer cells.
The MBCR SR occupies a total of 6,409 sf. of laboratory space on the 1st, 3rd and 4th floors in the Stanton L.
Young Biomedical Research Center (BRC) facility on the OUHSC campus. This central location provides the
27 BRC-based SCC members with immediate access to this important infrastructure. An additional five SCC
members are located in the adjacent Biomedical Sciences Building (BMSB), which has a dedicated internal
walkway to BRC. In 2016, 22% of the total number of MBCR SR users were SCC members with peer-reviewed
support. The facility also served 12 SCC members without peer-reviewed support. In 2016, SCC members
constituted 32% of the total users of this centralized institutional facility, which is by far the largest usage by a
department or disease-site group at OUHSC, highlighting the high utilization and impact that the facility has on
advancing research at the SCC. An incentive program initiated by the SCC covers 20% of all charged fees for
SCC members for services provided by all areas of the MBCR.